Administrative Core

The Administrative Core will oversee the overall Program Project, both the overall program management
aspects and its scientific aspects. A key Core responsibility will be to facilitate communication and collaboration
between the Scientific Projects and Cores within the Program Project, and the Administrative Core will act as a
central hub to which the Projects and Research Cores will report progress toward the Specific Aims, budgeting,
data sharing and communications. The Administrative Core will be responsible for the fiscal accountability of
the Program Project, in particular budgeting, accounting, effort reporting, and sub-contract management,
working with the Internal Advisory Committee (IAC) as to the proper allocation of resources for the projects as
needed with respect to budgeted items; relevant issues will be discussed and prioritized at biweekly Zoom
meetings which the Administrative Core will organize. Management responsibilities of the Core, in conjunction
with the IAC, will include prioritization and allocation of equipment, samples, personnel, and effort across all
scientific ventures. The Administrative Core will also be responsible for facilitating interactions with the External
Advisory Committee (EAC), as well as collaborations between this project, other relevant NIAID Projects, and
other relevant external radiation countermeasure programs. The Core will organize the Annual Program
Project Retreat, as well as the coupled Young Radiation Scientist Training Program. The Administrative Core
will coordinate patent applications and maintain intellectual property protections and will coordinate with the
Technology Transfer offices of the participating institutions to facilitate any requests for licensure or sharing of
new technologies. Finally, the Administrative Core will maintain the Program Project Website.